A Novel Human Laboratory Model of Resilience Among Individuals with Opioid Use Disorder

Despite vast economic investments to mitigate the harms of opioid use disorder (OUD), the prevalence of the
disorder remains high in addition to an estimated 80,000 Americans dying from opioid-related overdoses yearly.
Given the significant heterogeneity across multiple dimensions of OUD, prioritizing investigations of
multidimensional phenotypes such as resilience may improve our etiological understanding of the disorder. The
goal of the proposed study is to develop a laboratory model of resilience, allowing the objective examination of
this construct in a controlled laboratory setting. The study will employ a within-subjects, randomized design and
investigate associations of resilience with heroin-seeking and decision-making behaviors. In addition, this study
aims to better characterize resilience in individuals with OUD through a deep multidimensional psychological,
cognitive, and affective phenotyping approach. To accomplish these goals, individuals who meet DSM-5 criteria
for OUD will be recruited to achieve N=50 completers. Participants will be stabilized on oral morphine throughout
their 10-day inpatient stay to diminish confounding effects of acute withdrawal symptoms on study assessments.
The primary aim will be to assess whether Resilience Laboratory Tasks (control, cognitive and emotional
flexibility) demonstrate convergent validity with self-reported resilience under stress (Trier Social Stress Test,
TSST) and non-stress (non-stress test; NST) experimental conditions. Participants will undergo these two
experimental sessions (TSST and NST) in random order. During the sessions, heart rate (HR) and HR variability,
blood pressure, and galvanic skin response will be assessed as physiological measures of stress reactivity.
Immediately following the TSST and NST sessions, participants will complete self-report assessments of stress
(perceived stress, craving, and desire to use heroin), a Hypothetical Drug Purchase Task (proxy for heroin self-
administration) and Resilience Laboratory Tasks. This proposal will allow the validation of a novel laboratory
procedure to empirically examine resilience and provide preliminary data for the psychological, cognitive,
emotional, and behavioral substrates of this construct. Additionally, this K08 proposal will provide critical training
needed to achieve my career goal of becoming an independently funded scientist-clinician. Specifically, this
mentored award will advance my research career by (1) providing essential training in study design and
methodology to evaluate the convergent validity of measures of resilience using human stress paradigms, (2)
supporting the development of a valid multidimensional phenotypic assessment battery to characterize
heterogeneity across multiple dimensions of OUD, (3) improving my skills in advanced statistical methods and
allowing me to develop a fundamental understanding of computational modeling, (4) improving my manuscript
and grant record. The training goals outlined in this K08 resubmission will equip me with a unique set of skills in
human laboratory paradigms and computational modeling which, in combination with the pilot data collected as
part of the proposed research, will make me a highly competitive candidate for future R01 submissions.

Public health relevance
Narrative Resilience, characterized as the capacity to recover quickly from highly stressful or traumatic experiences, may lessen the gravity of negative consequences of opioid use disorder (OUD). This study seeks to achieve a better understanding of resilience through the development of a human laboratory model that integrates measurement of psychobiological components of resilience (e.g., emotional flexibility – the ability to flexibly regulate emotions in a context-appropriate manner) with behavioral measures of stress reactivity (e.g., heroin demand on the heroin purchase task – a proxy for heroin self-administration). Developing a laboratory model of resilience will permit investigating whether resilience is stable and if it can be improved—a prerequisite to measure the effects of any new intervention targeting resilience.